J. NRSA Training Core

Academic Medical Centers have the responsibility to train the next generation of biomedical scientists and
physician scientists for careers in clinical and translational research. Our Scientific Teams Advancing
Research Translations (START) Program will utilize a team science approach to develop the clinical and
translational research skills of graduate students and MD-fellows who align with CTSA goals of advancing
therapeutics, clinical interventions and behavioral modifications to improve health.
The Objectives of the START Program are to provide one year of stipend for graduate and MD-PhD students
and MD-fellows to conduct focused research and develop fundamental, quantitative skills involved in clinical and
translational research as components of a research PhD or MS (for scholars with clinical terminal degrees)
degree. Students participate in workshops that teach project development, grant writing, manuscript writing, and
other professional development skills, including best practice strategies to optimize communication skills,
particularly in communicating with a non-scientific audience. Students have Team Science experiences as a
vertically integrated training experience. Graduate- and MD-PhD students conducting clinical and translational
research will be matched with an MD-fellow to experience T3-T5 types of research projects directed to improve
population health. This will include activities with high school and undergraduates from our pipeline programs,
to reinforce the impact clinical and translational research has on human populations within our community. In
addition, students participate in bi-annual conferences to present their current studies in a team-based
environment and use the Individual Development Plan (IDP) to optimize the training experiences of our trainees.
The START Program organizes a workshop with the trainee’s mentors to establish best practice in mentoring.
START Program leadership also mentor graduates of START Program for successful careers as scientists and
physician-scientists at MCW.
The outcomes of the START Program align with the CTSA goals of advancing therapeutics, clinical interventions
and behavioral modifications to improve health.